SYNTHETIC ACTIVE SITES FOR CATALYSIS OF BOND FORMATION

The objective of this project is to construct two fully synthetic active sites (1.1') designed to catalyze bond formation. Each active site, which is an organic molecule with a molecular weight greater than 1,000, contains substrate binding sites and a catalytic unit and is intended to exhibit catalysis, selectivity and turnover. The two active sites will employ transition state stabilization to achieve their catalytic activity. The synthesis of 1/1: which takes advantage of the commercial availability of large subunits, should afford 1/1' by a highly convergent route in which the longest synthetic sequence is only about ten steps. The proposal outlines the strategies reflected in the design of 1/1' and details how individual elements in the concept of 1/1' (including substrate binding, transition state stabilization, proton transfer, flexibility vs rigidity, product release, turnover and selectively) will be incorporated, measured and optimized.